Biomechanical Validation of the Transfer Assessment Instrument (TAI)

DESCRIPTION (provided by applicant): Abstract For veterans who rely on wheelchairs for mobility, performing transfers is essential to achieving independence with activities of daily living. For example, transfers are required for getting into and out of bed, on and off a bath tub/shower seat, commode seat, motor vehicle seat and so on. Unfortunately transfers, along with wheelchair propulsion, weight relief and overhead activities are believed to largely contribute to the development of shoulder pain and injury. For individuals who rely are their arms for independence with ADL, the onset of pain or an overuse injury can be devastating leading to increased healthcare expenses, limitation in activity, depression, decreased societal participation and a reduced quality of life. Despite the importance of transfers to daily living and that transfers rank among the most strenuous wheelchair-related activities, there is a paucity of research on the biomechanics of transfers. During rehabilitation, achieving transfers in the safest and most efficient manner possible has traditionally been the goal of both the patient and clinician. However, there is wide variation in the amount and quality of transfer training that is provided in rehab. The ergonomics of performing transfers is crucial to maintaining maximal upper limb function and pain free limbs over time. The techniques taught to patients during rehab are not based on scientific evidence and there is not a uniform way of measuring performance. For these reasons, we developed the Transfer Assessment Instrument (TAI) a 29-item criterion-referenced construct comprised of three domains 1) preparing for a transfer, 2) use of conservation techniques, and 3) quality of the transfer. The instrument was designed to be used by therapists in the clinic to determine a patient's adherence with 'best' transfer techniques, identify targeted areas of intervention, and document performance outcomes pre-post transfer training, intervention (e.g. trunk orthosis) or change in medical status. The TAI includes items that address the ergonomics of transferring independently and dependently for patients who need assistance either from a caregiver or with transfer equipment. The intent of the proposed three-year study is to establish the psychometric rigor of the TAI with wheelchair users with SCI using a two-phase approach. In Phase 1, 100 subjects will be evaluated for initial psychometric analysis and tool refinement. In Phase 2, using the refined tool extensive biomechanical validation studies will be conducted with 70 individuals who independently perform wheelchair transfers. Tool validation is an important first step towards the effective translation of evidence-based practices into a clinical setting. As a result, the proposed work has great potential to improve the quality of care of veteran patients and reduce the incidence of upper limb pain and injuries. PUBLIC HEALTH RELEVANCE: For veterans who rely on wheelchairs for mobility, performing transfersis essential to achieving independence with activities of daily living. Unfortunately, transfers are believed to largely contribute to the development of shoulder pain and injury. Thus, it is important that patientslearn how to perform independent and dependent transfers with the least amount of stress on the upper limbs. Rehabilitation programs that use ergonomic principles when teaching transfer skills may help to reduce upper limb pain and injuries in veterans with lower limb impairment. Techniques currently taught during rehab are not based on scientific evidence and there is not a uniform way of measuring performance. This project is important because it validates a new tool that clinicians can apply in the clinic to help with teaching and evaluating 'best' transfer techniques. This project will also use the tool to identify patients in need of intervention and document the immediate effects in reducing the stress on the upper limbs.

Public health relevance
For veterans who rely on wheelchairs for mobility, performing transfersis essential to achieving independence with activities of daily living. Unfortunately, transfers are believed to largely contribute to the development of shoulder pain and injury. Thus, it is important that patientslearn how to perform independent and dependent transfers with the least amount of stress on the upper limbs. Rehabilitation programs that use ergonomic principles when teaching transfer skills may help to reduce upper limb pain and injuries in veterans with lower limb impairment. Techniques currently taught during rehab are not based on scientific evidence and there is not a uniform way of measuring performance. This project is important because it validates a new tool that clinicians can apply in the clinic to help with teaching and evaluating 'best' transfer techniques. This project will also use the tool to identify patients in need of intervention and document the immediate effects in reducing the stress on the upper limbs.